Center for Molecular Epidemiology

Abstract:
This application is being submitted in response to GM-22-005. Please
see the research plan, as the FOA specified to include it there.

Public health relevance
Narrative: This is not required per the FOA as the application is not a competing administrative supplement.